Aryl hydrocarbon receptor-mediated differential gene regulation - Mechanism of stanniocalcin 2 mediated protection against NAFLD

ABSTRACT
The Aryl Hydrocarbon Receptor (AhR) is a member of the Per-Arnt-Sim (PAS) domain protein family that
regulates adaptive and toxic responses to a variety of chemical pollutants, including polycyclic aromatic
hydrocarbons and halogenated aromatic hydrocarbons, most notably 2,3,7,8-tetrachlorodibenzo-p-dioxin
(TCDD). We observed that the newly identified endogenous AhR agonist, cinnabarinic acid (CA) does not
upregulate prototypical AhR target gene, Cyp1a1 and is not involved in xenobiotic regulation. On contrary, CA
induced expression of a novel AhR target gene, stanniocalcin 2 (Stc2) in liver. Our studies indicate that in
response to CA-treatment, AhR interacted dichotomously to xenobiotic response elements (XREs, 5'-GCGTG-
3') present within the Stc2 promoter regulating its expression. Additionally, this proposal capitalizes on our
recent observation that CA treatment protected against non-alcoholic fatty liver disease in an AhR-dependent
manner. The in vitro model that mimics fatty liver disease, showed significant role of STC2 in CA-specific AhR-
driven hepatoprotection. Moreover, we recently constructed hepatocyte-specific Stc2 conditional knockout
mice (Stc2-hKO) which showed exacerbated hepatic steatosis and metabolic deterioration. The studies
proposed in this renewal application are logical extension of our current award and hypothesize that the CA-
specific AhR-regulated hepatic STC2 signaling plays critical role in attenuation of lipogenesis resulting in
protection against non-alcoholic fatty liver disease. Using the Stc2-hKO mice, Specific Aim 1 of this application
will investigate role of in vivo STC2 signaling in AhR-mediated protection against steatohepatitis in response to
CA treatment. Specific Aim 2 will utilize lipidomics and single-nuclei transcriptomics to characterize CA-specific
STC2 mediated hepatoprotective pathways involved in the mitigation of lipogenesis. Specific Aim 3 will
investigate AhR-mediated regulation of Stc2 promoter in non-alcoholic fatty liver disease. The current
application will unravel mechanism of transcription regulation of Stc2 by CA-specific AhR activation and
characterize its significance against non-alcoholic fatty liver disease.

Public health relevance
PROJECT NARRATIVE Endogenous and exogenous Aryl hydrocarbon Receptor (AhR) agonists, cinnabarinic acid and 2,3,7,8- tetrachlorodibenzo-p-dioxin (TCDD) exhibit mutually exclusive transcription regulation of target genes, stanniocalcin 2 and cyp1a1 respectively with distinct physiological consequences. Cinnabarinic acid induced AhR-regulated stanniocalcin 2 provides hepatoprotection against non-alcoholic fatty liver disease. The experiments outlined in this proposal will characterize cinnabarinic acid-specific AhR-mediated regulation of stanniocalcin 2 and investigate mechanism by which AhR-stanniocalcin 2 signaling protect against steatohepatitis, which may prove instrumental in developing therapeutic strategies targeting hepatic diseases.